Identification and development of a small molecule probe for HNMT

During this reporting period, the collaborative team advanced lead optimization of the current series to enhance compound potency, selectivity, and in vitro ADME/Tox properties. X-ray co-crystal structure was solved at a CRO, providing critical insights for structure-based drug design.

In parallel, the computational chemistry team implemented a virtual reaction enumeration strategy using commercially available Enamine building blocks to generate analog libraries of the lead series. Systematic predictions through AI/ML models combined with structure-based docking led to the discovery of a highly potent inhibitor with 11 nM activity.

Additionally, a virtual screening campaign integrating machine learning and structure-based methods identified 316 hits, which were subsequently validated in experimental assays.